Electrical spectral imaging using magnetic resonance methods

The low-frequency electrical properties of biological tissue provide sensitive and valuable indications of cell
density, membrane properties, electrolyte concentrations and mobilities and the presence or absence of
disease, particularly at frequencies between 1 kHz and 1 MHz. Measurements of variations in these properties
between these frequencies provide a unique view of tissue state. Imaging of electrical properties, combined
with electrical spectroscopy, would allow subtle examination of both spatial and time-dependent tissue
characteristics that are important in the diagnosis and therapy of brain cancers. Unfortunately, relatively few
reports of tissue electrical properties are in this frequency range, because they involve invasive and often
error-prone procedures.
Several Magnetic Resonance Imaging (MRI)-based, non-invasive methods of imaging electrical property
distributions have recently been developed. However, these methods can only be used at high frequencies
(>100 MHz) or very low frequencies (<100 Hz). For example, the technique of Diffusion Tensor Magnetic
Resonance Electrical Impedance Tomography (DT-MREIT) combines MR diffusion tensor and MR phase
images to produce reconstruction of full anisotropic conductivity tensor images at very low frequencies.
However, present DT-MREIT techniques are restricted to measurement frequencies of around 10 Hz.
We now propose transforming MREIT methods to capture spectral effects over the frequency range from 10
Hz to 500 kHz. The new technique, multifrequency MREIT (MF-MREIT) will be validated using computational
models, cell and tissue phantoms and in-vivo using a rat model of brain cancer. The specific focus of the
project will be measuring and characterizing low-frequency electrical properties of cancer cell cultures and
tumors grown from these cells in rat brains. It is anticipated that these measurements will lead to better
understanding of tumor properties and aid in planning new electrical therapies that are increasingly being used
to successfully treat brain tumors. The technique will have further application in diverse areas, including
characterization of tissue responses to tumor treating fields, irreversible electroporation therapy, and
measurement of tissue properties for construction of accurate computational models used in planning
neuromodulation treatments.

Public health relevance
The way that living tissues conduct electricity depends on many factors including cell density and shape, electrolyte concentration, the presence or absence of malignancies and measurement frequency. Present methods of imaging electrical conductivity distributions using magnetic resonance imaging measure properties at either very low (ca. 10 Hz) or very high (130 MHz) frequencies, while electrical properties relevant to emerging cancer treatments are in the range between 1 kHz and 500 kHz. We propose establishing an innovative MRI method that will realize high-resolution imaging of electrical conductivity distributions at frequencies between 10 Hz and 500 kHz, enabling non-invasive imaging of properties that may both aid in cancer diagnosis and in planning of its treatment.